Rapid POC diagnostic for Candida species and multidrug resistance identification

PROJECT SUMMARY Invasive candidiasis is a serious and widely recognized fungal infection caused by Candida species. Antifungal resistance is a particular problem with Candida infections. Multidrug-resistant Candida infections have very few remaining treatment options. The type and level of drug resistance is unknown until the causative Candida species is determined via culture methods. A rapid diagnostic test to both identify Candida species and its antifungal drug resistance would help provide timely, appropriate treatment and reduce the spread of these resistant organisms. In response to a research topic that is specified by CDC for a culture-independent platform technology for Candida diagnosis and resistance identification for point-of-care/ low-resource settings, Lynntech proposes to develop a rapid, inexpensive, specific, and sensitive diagnostic that enables point-of-care Candida species and multidrug resistance identification without the need to rely on culture results. The innovation of our diagnostic test is effectively bringing highly sensitive molecular testing to point-of-care. Lynntech’s diagnostic test could potentially represent a significant new paradigm in point-of-care diagnosis to guide accurate therapy for Candida infections and help maximize positive patient outcomes.

Public health relevance
PROJECT NARRATIVE Invasive candidiasis is a serious fungal infection caused by Candida species that usually confer resistance to antifungal drugs. A rapid diagnostic test to both identify Candida species and detect antifungal drug resistance would help provide timely, appropriate treatment and reduce the spread of these resistant organisms. Lynntech proposes to develop an inexpensive, specific, sensitive, point-of-care amenable, user friendly and rapid diagnostic for Candida species and multidrug resistance identification to enable effective, non-empirical therapeutic prescription without the need to rely on culture results.